Training in Alcohol Research

The goal of this training program is to prepare predoctoral students and postdoctoral fellows with knowledge and skills to carry out cutting-edge alcohol research. For the past 35 years, the Alcohol Research Training Program at MUSC has created an environment where basic scientists and clinicians work together to train the next generation of alcohol researchers. The objectives of this training program are to: 1) integrate trainees into funded alcohol research programs with appropriate mentors, 2) provide a strong foundation in research design, analytical techniques and data presentation relevant for AUD research, 3) provide trainees with exposure to appropriate role models and opportunities for mentoring, 4) provide instruction in issues related to scientific ethics, and methods for enhancing rigor and reproducibility of scientific results, 5) enhance communication skills, 6) teach trainees how to prepare a research focused grant application needed to transition to an individual training award, 7) help each fellow gain an appreciation of both clinical and basic science research to enhance their understanding of how their training relates to health and disease, and 8) assist trainees in professional development and career advancement. Over the past decade, there has been outstanding growth and success of faculty devoted to alcohol research that has contributed to MUSC’s stature as a center for alcohol and substance-use research. This has generated a high demand for predoctoral and postdoctoral training in alcohol research. Seven major research areas are available for training: 1) elucidating brain targets of alcohol action, 2) uncovering the neurobiological basis of excessive drinking, 3) advanced brain imaging and stimulation techniques in human AUD subjects, 4) determining the cognitive aspects of alcohol use and dependence, 5) evaluating novel pharmacotherapies for treating AUD, 6) analyzing how genetic polymorphisms contribute to alcohol use and treatment efficacy, and 7) studying how stress and trauma contribute to alcohol use and dependence. Training takes place within a tightly integrated and physically connected environment where educational and research opportunities are closely coordinated. The comprehensive training program incorporates didactic material, clinical experiences and research opportunities. Recruitment and selection of trainees is accomplished by the Program Directors and Executive Committee members. Mentors are faculty with actively funded alcohol research projects and matching of trainees with mentors is by mutual consent. The NIAAA training program has been successful in placing trainees in highly-productive postdoctoral and faculty- level positions through which they continue to contribute to alcohol research.

Public health relevance
PROJECT NARRATIVE Alcohol use disorder (AUD) is a major public health concern both in terms of its impact on personal and family relationships and its tremendous economic costs due to lost productivity and health-related impairments. Improving the effectiveness of treatment of AUD requires improving our understanding of the neurobiological basis of addiction and the limitations of currently available intervention approaches. The proposed project will provide advanced training to both clinical and basic science researchers that will provide them with the knowledge base and research skills to investigate the neurobiology of addiction and develop improved therapeutic strategies to treat AUD.